Harnessing YAP-TEAD Activity as Anti-Invasion Therapeutic in Human Glioblastoma

Project Summary: Current glioblastoma (GBM) therapy fails to target the invasive nature of tumor spread,
responsible for recurrence and disease progression. A better understanding of tumor biology at the infiltrative
margin, and improved combination therapy that targets not only proliferation but also migration, is urgently
needed for all GBM patients. For the past decade, our group has been at the forefront of focused efforts to
elucidate further the biology of glioma migration and supported through this R01 we have implicated the
important role of Hippo effectors YAP/TAZ-TEAD as anti-invasive GBM targets. The Hippo pathway integrates
complex chemical, cytoskeletal and mechanical cues related to cell movement, which converge on the nuclear
translocation of the YAP oncoprotein, or its paralog TAZ, and their co-activation of the TEAD family of
transcription factors. Our lab uncovered TEAD1 as a critical driver of migration in glioma stem-like populations,
and subsequently showed anti-invasive and survival efficacy of the YAP-TEAD inhibitor Verteporfin (VP) in
primary and recurrent GBM models, as monotherapy or in combination with standard-of-care (SOC) therapy,
the latter potentially resensitizing chemoresistant tumor cells to Temozolomide (TMZ). In parallel, others have
shown YAP/TAZ as critical drivers of stemness and plasticity in GBM, supporting the exciting overarching
hypothesis that oncogenic convergence on YAP-TEAD can be harnessed as new and effective GBM therapy.
With VP progressing to phase I/II trials in recurrent EGFR-mutant GBM patients, our studies advance several
urgent and clinically relevant limitations regarding the need for new therapeutic strategies, such as oral drug
administration of YAP-TEAD inhibitors in an outpatient setting; the preclinical efficacy of such therapy across
GBM subtypes, including in primary and in non EGFR-mutant GBM, in combination with SOC therapy; and the
necessity to establish rational biomarkers of response for YAP-TEAD inhibitors that assess both tumor cells
and their microenvironment at the infiltrative margin, the niche that recapitulates best the residual disease
being targeted by oncologists. Leveraging our expertise and preliminary data, we address these in three
translational aims: 1) Repurpose new YAP-TEAD inhibitors with oral bioavailability, including nanoVP and
Vivace (VT) formulations with superior pharmacodynamics and pharmacokinetics (PK/PD), for future clinical
use in GBM; 2) Predict synergy of VP/VT with standard-of-care therapy across primary and recurrent GBM; 3)
Define YAP-TEAD vulnerabilities at the margin as biomarkers of durable treatment response. We use
innovative single-cell resolution spatial transcriptomics, matched primary/recurrent preclinical GBM models and
human samples, and uniquely focus on biology at the infiltrative margin. This analysis will define biomarkers of
response in clinically optimized YAP-TEAD inhibitors relevant for ongoing VP/VT clinical trials and elicit which
GBM is most likely to benefit from combination therapy with SOC, justifying expansion of trial eligibility criteria.

Public health relevance
Narrative Current therapy in glioblastoma fails to target the invasive nature of tumor growth responsible for disease progression. This renewal advances our prior efforts to define GBM migration drivers, towards a clinically relevant goal of repurposing YAP-TEAD inhibitors as anti-invasion therapeutics, by screening for drugs with optimal oral bioavailability and preclinical efficacy and defining rational biomarkers of response across primary and recurrent tumor subtypes.